Interdisciplinary Training in Genome Sciences

ABSTRACT
We request funds to continue the interdisciplinary training program in genomics at the University of
Washington and affiliated institutions. The program focuses on preparing pre- and postdoctoral trainees for
a research career in genomics and computational biology with an emphasis on translational research.
Trainees will engage in projects that include discovering how a genome encodes the information for RNAs,
proteins and its own structure and replication; measuring and analyzing sequence variation; developing
technologies for high-throughput experimental assays including-next generation sequencing; and
generating computational tools to analyze genomic variants and their impact on mRNA and protein function.
As these research challenges demand interdisciplinary approaches and multidisciplinary collaborations, one
goal of this program is to attract individuals trained in computer science, statistics, physics, and engineering
to biological research. Another goal is to train cellular and molecular biologists to incorporate genomic-
based quantitative analyses in their research to allow them to effectively collaborate at this interdisciplinary
interface. Given the wide diversity in educational backgrounds and career goals among our trainees, the
program emphasizes highly individualized training programs and interdisciplinary research. A
multidisciplinary group of 51 faculty, selected for their involvement in genome analysis and their strong
record of collaborative interactions, comprises the training team. Research experience is complemented
with a variety of didactic courses and electives. The trainees are also exposed to discussions on ethical
research conduct and the ethical, legal, and social implications of genomic research. Breadth of knowledge
and program cohesion are achieved through trainee participation in two seminar series that feature genomic
research and computational biology, journal clubs, and research reports. In the coming five years, we will
continue to expand our program in genomics, proteomics, instrumentation development, computational
biology, and statistical genomics. We request funds to train 12 predoctoral and 4 postdoctoral fellows per
year. The trainees will emerge with the skills necessary for success in the academic and biomedical
research environment of the 21st century made possible by advances in genomics.

Public health relevance
NARRATIVE Genomics is integral to modern biomedical research and diagnosis. Genome-wide studies are used to identify potential genetic causes of disease and investigate fundamental questions of biology and development. Our program will train pre- and postdoctoral trainees for future biomedical and interdisciplinary research in genomics, proteomics and computational biology.